Long-term Effects of a household Air Pollution intervention: Follow-up of a randomized controlled trial

SUMMARY
Project Title: Long-term Effects of a household Air Pollution intervention: Follow-up of a randomized
controlled trial
Globally, nearly 3 billion people are exposed to household air pollution (HAP) from the use of solid fuels
(biomass or coal) for cooking and heating. In 2019, HAP accounted for an estimated 2.3 million premature
deaths and 3.6% of global disability-adjusted life years lost. As a strategy to mitigate HAP and improve health
outcomes, we recently completed an 18-month intervention of liquefied petroleum gas (LPG) stoves and fuel
(HAPIN trial; UM1HL134590, MPIs: Checkley, Clasen, Peel), however current evidence suggests that the
health benefits of HAP reduction may not become apparent until several years later. Leveraging the
participant cohort and comprehensive data collected in the HAPIN trial, we seek to determine the long-
term effects of an 18-month LPG stove, continuous fuel and behavioral messaging intervention
on health outcomes among children in Puno, Peru (n=709). We will measure clinical outcomes, kitchen
concentrations and personal exposures to PM2.5 once yearly and monitor biomass cooking stoves continuously
using temperature loggers throughout the study period. We will examine whether health outcomes of
intervention participants (lung function, cardiovascular risk profile, and neurodevelopmental outcomes) differ to
those from control households through age eight and conduct exposure-response analyses based on the PM2.5
exposure and stove use data during the intervention and subsequent follow-up period. Additionally, we will
evaluate if intervention households continue to use LPG for a higher percentage of cooking time than controls
and to experience lower PM2.5 exposures.
This study will provide valuable insight on the longer-term effects
of HAP mitigation during a critical period of child development and generate evidence which can inform
government policies for clean fuel intervention programs. Moreover, it will contribute unique data on pediatric
lung function measures and childhood cardiovascular disease risk, which is currently limited in low- and
middle-income countries.

Public health relevance
NARRATIVE Project Title: Long-term Effects of a household Air Pollution intervention: Follow-up of a randomized controlled trial This proposal seeks to evaluate the long-term effects of an 18-month clean fuel intervention in Puno, Peru, on lung function, cardiovascular disease risk and neurodevelopmental outcomes in children. We will measure clinical outcomes, kitchen concentrations and personal exposures to PM2.5 once yearly and monitor biomass stoves continuously throughout the study period. We will examine whether health outcomes of intervention participants differ to those from control households through the child’s eighth birthday and conduct exposure- response analyses based on the PM2.5 exposure and stove use data during the intervention and subsequent follow-up period.